Integrated Microphysiological System of Cerebral Organoid and Blood Vessel for Disease Modeling and Neuropsychiatric Drug screening

Abstract
Many neuropsychiatric disorders such as autism, epilepsy, schizophrenia, and
intellectual disability start early in life and often contribute to a lifetime disability. The
rising incidence of these disorders is expected to cause a major public health challenge
in the coming decades. Despite the impending challenge, drug development for these
disorders is facing a crisis; most major pharmaceutical companies have reduced their
investment in psychiatric drug development because of a high failure rate. Limitations
associated with animal models and a dearth of druggable biological targets, coupled with
poor access to the living human brain for dynamic observation and experimentation all
conspire to impose an enormous challenge of finding effective psychiatric drugs. Recent
advances in human induced pluripotent stem cells (hiPSC) have made it possible to
create a patient-specific brain-like neural tissue (referred to as `cerebral organoid') that
displays an architecture and neural network activity resembling that of human tissue.
These cerebral organoids (CO) offer researchers an exciting opportunity to investigate
disease mechanisms responsible for the development of neuropsychiatric disorders in
humans. We propose in this project to link CO with a tissue-engineered blood vessel (BV)
and their blood-brain barrier (BBB) interface to form a cerebral microphysiological
system (CMPS). There is documented anatomical parallelism between vessel and nerve
patterning and development, and it has also emerged that neuron and vessel
specification, growth, navigation, and survival share many molecular pathways. The
same signaling pathways also play a critical role in the crosstalk between nerves and
vessels during the injury repair process in adult brain. Therefore, it is important to
understand the interactions between the CNS and the vascular system under
physiological and pathophysiological conditions. We propose to use two well-defined
genetic lesions, the 22q11.2 deletion syndrome (22q11.2DS or DiGeorge syndrome) and
the Proteus syndrome, that affect both the CNS and vascular systems for the
development and validation of CMPS. The proposed CMPS, if successful, will offer a
powerful platform to screen neuropsychiatric drugs as well as to develop novel
neuropsychiatric treatment strategies that target the shared mechanisms between the
CNS and the vascular system.

Public health relevance
Narrative Psychiatric drug development has a high failure rate because of inadequate animal models and poor access to the living human brain for dynamic observation and molecular investigations. We propose to generate human induced pluripotent stem cell- based cerebral organoids that can resemble the structure and functions of a human brain tissue. Using DiGeorge Syndrome and Proteus Syndrome as our disease models, we will develop a cerebral microsphysiological unit for disease modeling and psychiatric drug screening.